Remote Exposome Monitoring for Autoimmune Diseases

Project Summary
The exposome, defined as the measure of all exposures for an individual and how those exposures relate to
an individual's health, plays a key role in many autoimmune diseases. Measuring the exposome over time and
understanding its effect on human health using sophisticated readouts such as -omics assays is a key priority
for future clinical and translational studies. However, one of the major barriers to conducting such longitudinal
exposome studies is their frequent reliance on in-person clinical research visits. In-person research visits, often
requiring time-consuming travel to an academic medical center and absence from work, can significantly limit
the geographic, racial, and socioeconomic representation of research participants. These in-person visits also
typically occur every few months, limiting the temporal resolution of exposome data that can be measured.
This proposal focuses on the implementation of innovative strategies for remote, home-based exposome
monitoring and -omics measurements. Successful completion of this work will provide valuable resources for a
future collaborative network studying the exposome.

Public health relevance
Project Narrative Autoimmune diseases are greatly influenced by environmental factors. In this proposal, we use innovative data collection methods to monitor environmental factors and autoimmune disease activity. These novel tools may be of great benefit to future investigators conducting similar studies.